A RANDOMIZED CONTROLLED TRIAL OF THE SAFETY AND EFFICACY OF TWO TREATMENTS

This study will investigate the efficacy and safety of the two treatment protocols for Infasurf administration while comparing incidence of pulmonary hemorrhage, respiratory support requirements pre, intra and post surfactant administration and compare survival to 28 days and beyond 28 days.